Heterogeneity and cellular hierarchy of lung cDC2

Abstract
Dendritic cells (DCs) play a fundamental role in bridging innate and adaptive immunity. Among DC subtypes,
conventional DC2 (cDC2) are pivotal in multiple diseases including allergy, fungal & parasite infection, and
cancer. However, studying cDC2 has been challenged by the small cell number and a lack of the subset-
specific animal model. To better understand the characteristics and roles of cDC2 subsets, we have utilized the
cutting-edge, RNA-based high-throughput transcriptomic profiling technique known as single cell RNA-
sequencing (scRNA-seq). This approach has enabled us to better understand lung cDC2 in terms of diversity
and cellular hierarchy.
Our preliminary data indicate that lung cDC2 can be categorized into 6 distinct subsets. Of interest, lung
CX3CR1hicDC2 subset are origin of rest of 5 subsets. In aim 1, we will test whether other lung cDC2 subsets
are derived from the CX3CR1hicDC2 subset. In aim 2, we will test whether a cDC-specific CX3CR1 depletable
stain (CX3CR1-DTRcDC) is responsible not only Th2 immunity but also Th17 immune responses.
Successful completion of this project will provide us with a better understanding of heterogeneity and cellular
dynamic lineage trajectory of lung cDC2. Moreover, our new mouse strain, cDC specific CX3CR1 depletable
strain (CX3CR1-DTRcDC), will be a great asset to study cDC2-mediated diseases.

Public health relevance
Project Narrative Although conventional dendritic cell type 2 (cDC2) plays a pivotal role in multiple diseases, the cDC2 specific mouse model is undeveloped. This proposal investigates CX3CR1+cDC2-mediated cellular hierarchy of lung cDC2 and suggests the CX3CR1+cDC2 is a key player in cDC2 associated disease.